Predoctoral Training Program in Genetics

This proposal is to continue NIH support for predoctoral training within the interdepartmental
Training Program in Genetics (TPG) of Yale University. In a typical year, there are ~35-40 TPG
trainees, of which the TPG financially supports 14 2nd and 3rd year students. Sixty-five faculty
are TPG trainers. The principal administrative and training entities are within three departments:
the departments of Molecular, Cellular and Developmental Biology (MCDB) and Ecology and
Evolutionary Biology (EEB) in the FAS, and Genetics at the Yale Medical School. The program,
which is overseen by two co-Directors, Valerie Reinke and John Carlson, supports training in all
aspects of modern genetics. Candidate students enter Yale via application to either the umbrella
program Biological and Biomedical Sciences (BBS) or to the EEB department. At the end of
year 1, students with a research interest in genetics and who are in the lab of participating TPG
faculty fill out a formal application to join the TPG. The TPG advisory panel reviews the
applications and selects the most appropriate student to be appointed to the TPG. The TPG has
multiple training activities, including an annual student-organized symposium, a research-in-
progress seminar series, and various workshops for scientific and career development.
Importantly, multiple training initiatives specific to this program have been added during the last
funding period, including a TPG retreat, an outside speaker seminar series, and additional
mentoring for both trainees and junior faculty trainers. All students perform at least one-year of
supervised teaching and receive travel funds to attend and present their work at national or
international scientific meetings. All TPG students are mentored by the TPG directors, in
addition to their thesis committee. Starting in fall 2011, the students received full institutional
support (stipend, tuition and health benefits) from Yale during their first year, which includes
formal course work and three research rotations. The majority of graduates go on to leading
positions in academic and research institutions or in biotechnology and pharmaceutical
companies.

Public health relevance
The Predoctoral Training Program in Genetics at Yale University supports the education of the next generation of research scientists in genetics. Graduates from this program go on to leading positions in universities, research institutes, and industry, where they contribute to finding medical and practical solutions to genetic diseases, cancers, and other disorders that afflict humans.